iAmHealthy Parents First

Project Summary/Abstract
Both children and adults in rural areas have higher obesity rates than their urban counterparts. With less access
to evidence-based weight loss interventions, obesity poses a major risk factor contributing to elevated morbidity
and mortality from cardiovascular disease, diabetes, and cancer among rural Americans. Obesity runs in families
due to multiple factors including hereditary components, home environment, and behavioral modeling around
dietary intake, physical activity, and screen time. Thus, targeting the rural family unit has the potential to enhance
weight loss for adults and children simultaneously. Previous research from our team indicates that mHealth is
feasible and acceptable for the delivery of obesity interventions to rural families as this type of intervention lowers
child Body Mass Index z score (BMIz) and helps children and families to significantly change their health
behaviors. The current application extends this work in a new and innovative direction, targeting parents first
with an empirically supported obesity intervention, and then moving on to treat the family unit. In a randomized
trial, we propose to compare a 4-month parent-only intervention followed by a 6-month family based behavioral
group intervention (iAmHealthy-Parents First) to a parent wait-list control followed by the family based
behavioral group intervention (iAmHealthy). Parent/child dyads will be recruited from both rural elementary
schools and rural medical clinics in 8 towns. Each town will consist of a single site and will recruit 30 parent/child
dyads, 15 of whom will be randomly assigned to iAmHealthy-Parents First and 15 to iAmHealthy, for a total of
240 parents and 240 children. Each rural town will have a population < 20,000 and/or the Rural Urban Commuting
Area Codes of 4 or greater, and for the purposes of the study will include a nurse at a rural health clinic partnering
with a nurse at a rural elementary school to make a single site. In Aim 1 we propose to study effectiveness
through change in child BMIz and parent percent weight loss from baseline to month 10 (post-intervention), as
well as through change in diet, change in physical activity and change in parent and child weight related quality
of life. In Aim 2, we propose to assess mediators and moderators that we believe are specifically important to
the treatment model and to the rural population. In Aim 3 we propose to explore the reach and representativeness
of the intervention, and to explore a concept we have found key in both our adult and pediatric trials – nurse
engagement. Our experience suggests that nurse engagement plays a key role in recruitment, retention, and
engagement of the families, and here we propose to assess nurse engagement as well as foster it through the
development of a Rural Nurse Engagement Collaborative. This exploratory aim will provide critical pragmatic
data to inform future studies aimed at testing local implementation and dissemination strategies. The iAmHealthy
Parents First intervention is an easily scalable, widely disseminable obesity intervention option which could
significantly improve the way we treat obesity among rural families.

Public health relevance
Project Narrative Certain populations are disproportionately affected by obesity, such as families in rural areas, and treatment options for these rural children and families are limited as they face unique barriers. The current study will assess the effectiveness of iAmHealthy Parents First (a 4-month parent-only intervention followed by a 6-month family- based program) compared to iAmHealthy alone (a parent wait-list control followed by the family based program). If effective, this intervention model could easily be disseminated to improve the lives of rural children and parents who need weight management treatment.